Synaptic Control of Glutamate Homeostasis

Homeostatic signaling systems are crucial forms of biological regulation that permit flexible yet
stable information transfer in the nervous system. These fundamental mechanisms operate to
maintain such properties as synaptic strength and glutamate levels within stable physiological
ranges. Although intensive research has been focused on understanding how excitatory synapses
are homeostatically modulated to stabilize synaptic strength, far less is known about how these
synapses adjust to control glutamate release itself. Excess glutamate release can lead to a variety
of diseases and dysfunctions in the nervous system, contributing to seizures, excitotoxity, and
neurodegeneration. Here, we propose to characterize a glutamate homeostat that controls
presynaptic function using the Drosophila neuromuscular junction as a unique and powerful model
system. At this glutamatergic synapse, excess presynaptic glutamate secretion induces a
homeostatic inhibition of neurotransmitter release, an adaptation referred to as presynaptic
homeostatic depression (PHD). This process parallels a similar phenomenon observed in a
variety of other organisms, including mammalian central synapses. We hypothesize that excess
glutamate is sensed by a presynaptic glutamate receptor and activates an autocrine signaling
system to homeostatically depress synaptic vesicle release. To test this model, we will use a
systematic electrophysiology screen to test glutamate receptors in Drosophila for roles in PHD.
Next, we will leverage a combination of cell biology, heterologous expression, pharmacology, and
innovative functional imaging techniques to determine the mechanisms through which excess
glutamate signals a precise reduction in presynaptic vesicle release. Finally, we will assess how
synapses, neurons, and glia adapt to chronic glutamate imbalance using several approaches,
including a cell-specific translational profiling technology we have developed as well as a new
generation of glutamate indicators. Together, these experiments will advance our understanding
of the mechanisms that endow synapses with the ability homeostatically tune glutamate release,
and will identify maladaptive responses to glutamate imbalance in the nervous system. Ultimately,
this knowledge will inform therapeutic strategies towards counteracting diseases associated with
glutamate imbalance, including epilepsy, fragile X syndrome and neurodegeneration.

Public health relevance
Defects in the homeostatic control of synaptic strength and glutamate imbalance have been implicated in a variety of neurological and neuropsychiatric diseases including epilepsy, schizophrenia, autism, Fragile X Syndrome, ALS, and Alzheimer's Disease. However, the mechanisms that ensure proper homeostatic control and prevent glutamate toxicity are enigmatic. This proposal will define the mechanisms that enable synaptic and glutamate homeostasis, and reveal how synapses adapt to glutamate imbalance. Outcomes of this work will reveal new insights into role of glutamate imbalance in a variety of diseases, and inspire new therapeutic approaches to prevent and treat chronic glutamate toxicity.